Core B: Research Development

CORE B: RESEARCH DEVELOPMENT - SUMMARY/ABSTRACT
The Research Development Core B provides support for Pilot Projects for junior faculty, or more rarely, more
senior faculty who wish to enter the field of aging. Pilot Project Support fulfills two main objectives. First, as
shown from our record of past performance, they can be an important part of the support for junior faculty who
are embarking on new projects that may not yet have achieved outside funding. Second, and less often, they
can play a similar role for more senior faculty who are changing career objectives in order to study the basic
biology of aging for the first time. The vast majority of awards will be targeted to candidates outside our region.
These awards will provide fully subsidized access to our Resource Core services, necessary reagents and
supplies, statistical support at every stage of the project, and mentoring by a senior faculty member. This
activity is directed by the Core Leaders in concert with the Executive Committee of our Nathan Shock Center.
We present 1) a plan for the advertising, review and selection of investigators to receive support; 2) a plan for
administration of award; 3) a plan for the mentorship and monitoring of individuals who will be selected for
these positions.